Modulating the DNA Damage Repair System in Traumatic Optic Neuropathy

PROJECT SUMMARY
Traumatic optic neuropathy (TON) is a rare and devastating condition with no effective treatment, leading to
irreversible vision loss. The long-term goal of this proposal is to develop novel therapeutic strategies to
promote retinal ganglion cell (RGC) survival and axonal regeneration following optic nerve injury. This aligns
with the NEI area of emphasis to understand the visual neuroscience underlying the relay of visual information
from the retina to the brain. The objective of this proposal is to investigate the role of DNA damage response
(DDR) pathways, specifically inhibition of checkpoint kinase 1 (Chk1), in enhancing RGC survival and
promoting neuroprotection. The central hypothesis is that modulating Chk1 activity can prevent RGC apoptosis
and promote survival after injury. The rationale underlying this proposal is that targeting DDR pathways will
identify new molecular targets for therapeutic intervention in TON, providing potential treatments that can be
applied to other optic neuropathies due to orbital disease, including compressive optic neuropathy and
radiation-induced optic neuropathy. The central hypothesis will be tested by pursuing three specific aims: 1)
determine whether Chk1 inhibition or a combination of Chk1/Chk2 inhibition in responsible for increased RGC
survival in vitro; 2) characterize the function of Chk1 isoforms in RGCs and identify their molecular partners
using immunoprecipitation-mass spectrometry (IP-MS); and 3) investigate the role of Chk1 in mouse models of
traumatic optic neuropathy. These aims will be evaluated using an innovative approach that combines
pharmacological screens, siRNA knockdown, and advanced molecular techniques in both cultured mouse
RGCs and mouse models of optic nerve injury. The proposed research is significant because it has the
potential to uncover novel mechanisms of RGC neuroprotection and identify new therapeutic targets for optic
neuropathies. The expected outcome of this work is an improved understanding of how DDR modulation can
enhance RGC survival and function following injury.
These results will have an important and immediate impact because they will establish a new approach to
treating optic neuropathies by targeting the DDR involved in RGC death and survival. The findings from this
study will provide the foundation for an R01 grant focused on further preclinical testing and eventually
translating these findings into clinical applications for patients with optic nerve injuries. To accomplish the
experiments proposed in this grant, I will need to expand my current knowledge through dedicated course work
and mentorship, which will be essential to my development as an independent clinician-scientist.

Public health relevance
PROJECT NARRATIVE This research aims to develop new therapeutic strategies for traumatic optic neuropathy (TON), a condition that currently has no effective treatments and leads to irreversible vision loss. By investigating the role of DNA damage response pathways in retinal ganglion cell survival, this work seeks to uncover novel mechanisms of neuroprotection that can be applied to TON as well as other optic neuropathies. This aligns with the National Eye Institute's (NEI) strategic goal to drive innovative vision neuroscience with the ultimate goal of reducing disability through improved visual outcomes.